Clinical and Translational Science Award

PARENT AWARD - PROJECT SUMMARY The translation and implementation of groundbreaking biomedical discoveries requires the dynamic coordination of multi-disciplinary partnerships with diverse expertise, interests, and skills. The New York University (NYU) Clinical and Translational Science Institute (CTSI) represents an innovative public–private partnership designed to foster clinical and translational research, adopt evidence-based therapies, and apply scientific discoveries to transform the delivery of medical care and improve health. The CTSI successfully leveraged a partnership of institutions with unique and complementary strengths to translate science into better health, including: NYU, a private research university with a history of public service, substantial biomedical, behavioral, and population health expertise, and robust education and training programs; New York City Health and Hospitals (H+H), the largest municipal healthcare system in the United States; Nathan Kline Institute (NKI), a state psychiatric institute affiliated with NYU; and community organizations representing the richly diverse population of NYC. As the centralized hub that coordinates and integrates activities across these partners, our CTSI catalyzes research and facilitates access to essential core services, resources, and expertise necessary to engage in the full spectrum of clinical and translational research across our partner institutions. We provide educational and training opportunities for our diverse research workforce. Moreover, the CTSI serves as a nexus for collaboration between investigators at our partner institutions and the nationwide network of CTSA hubs. We more than doubled self-identified clinical and translational research at our hub over the past 10 years and established collaborations between NYU, the schools and colleges of NYU, and H+H to further accelerate the pace and impact of discovery, development, validation, and implementation across the full spectrum of translational research. We now propose an array of innovative and evidence-based strategies within the framework of the strategic domains enunciated by NCATS including: 1) Methods/Processes to streamline regulatory processes, improve the efficiency, quality, and reproducibility of research and increase the rate of implementation of research advances; 2) Collaboration/Engagement with communities, patients, providers, and researchers to elucidate and disseminate best practices and guiding principles of team science to improve translational research and health outcomes; 3) Informatics to provide a strong and innovative digital environment for subject recruitment, data management, analysis, discovery, and sharing as well as access to an extensive digital warehouse with data from electronic health records, epidemiologic studies, clinical trials, multi-omic analyses, and biospecimens; 4) Integration Across the Lifespan with Community and Patient Stakeholders to engage diverse NYC communities and special populations across the lifespan; and 5) Workforce Development to advance our efforts to educate, train, and cultivate the next generation of the translational research workforce.

Public health relevance
PARENT AWARD – PROJECT NARRATIVE Continued acceleration of the pace of discovery has increased the challenge of bringing the fruits of scientific discoveries to our community. The NYU-H+H CTSI supports more rapid translation of scientific advances into medical breakthroughs by partnering NYU's scientific and educational resources with both the largest metropolitan healthcare system (H+H) in the US and our remarkably diverse community.